Micro-RNAs: a new mechanism negatively regulating B cell responses in the elderly

DESCRIPTION (provided by applicant): Aging generates a decline in the ability of the individual to mount protective immune responses. The aged immune system also negatively impacts other important systems, such as the cardiac and nervous systems, by contributing to increased inflammation. The aged immune system not only impacts the quality of life of the individual but also the ability to be protected from infectious agents and cancers. We have shown that aging is associated with autonomous defects in B cells which are important for optimal health because they produce antibodies necessary for responses to vaccines and infectious diseases as well as other functions. These defects/biomarkers include: immunoglobulin (Ig) class switch recombination (CSR), activation-induced cytidine deaminase (AID) and the transcription factor E47. AID is necessary for CSR, the process that generates protective antibodies, and is a good measure of B cell function. We hypothesize that a mechanism for the aged impairment in B cell function, for which we have preliminary data, is that microRNA (miR)-155, miR-16 and other miRs are significantly higher in aged as compared with young adult unstimulated human B cells, making them refractory to further stimulation with the result of lower levels of AID induced after B cell stimulation. The objectives of this proposal are to identify miRs up-regulated in unstimulated B cells from elderly individuals, characterize the molecular pathways for their up-regulation as well as their mechanism of action, and begin to correct these defects by designing oligonucleotides which target these miRs. We propose to sort subsets of B cells, perform a miR microarray and correlate levels of the most increased miRs with AID. In the second aim we will identify molecular mechanisms for increases of particular miRs in aged B cells as well as for particular miRs down-regulating AID. In the third aim we will evaluate if lower in vitro CSR can be rescued by adding oligonucleotides blocking particular miR function (antagomirs) to B cell cultures. The experiments proposed in this grant offer an innovative approach to further characterize mechanisms which decrease B cell responses in elderly individuals. These studies should contribute to development of effective therapeutic strategies to protect elderly individuals from diseases typical of old age.

Public health relevance
The studies proposed here investigate new molecular mechanisms for decreased human B cell function in the elderly, important for optimal response to vaccines, infectious diseases, and cancer. The results from the studies proposed here will also help design new protocols of intervention for the improvement of antibody responses in the elderly.